Physiologic response to bariatric surgery and the impact of adjunct semaglutide - in adolescents (the PRESSURE trial)

PROJECT SUMMARY/ABSTRACT
Metabolic and bariatric surgery (MBS) to treat pediatric severe obesity is increasingly common. MBS at younger
ages means decades longer to preserve or enhance its cardiometabolic and other health benefits. While mean
weight loss after MBS is substantial, >50% of adolescents in prospective US cohorts have persistent severe
obesity >3 years later. We have also found that 25% of youth show significant weight regain 6 months through
5 years postoperatively. Additionally, comorbidity response to MBS appears to differ between youth and adults.
In youth, few predictors of weight loss after MBS are known and there is insufficient mechanistic data evaluating
physiologic factors as potential predictors. Further, there is an absence of in-depth cardiometabolic phenotyping,
which could help to define residual risk post MBS beyond weight loss alone. We hypothesize that 1) physiologic
phenotypes in gut peptides, body composition, and resting metabolic rate (RMR) will partially explain variability
in MBS weight loss in adolescents (Aim 1), that improved insulin sensitivity (IS) will be associated with favorable
cardiovascular changes independent of BMI change (Aim 2), and 2) Adjunctive postoperative glucagon-like
peptide-1 (GLP-1) pharmacotherapy will augment MBS benefits in youth with suboptimal surgical response. I
propose a 2-phase design: a 1-year prospective study measuring changes in gut peptides, body composition,
RMR, and cardiometabolic measures (IS, 24 hour blood pressure, echocardiogram for structure/function, arterial
stiffness, cardiac autonomic function) from pre- to 1 year post-MBS (n=30), 2) A randomized, double-blinded, 6-
month intervention of semaglutide vs placebo 1-2 years postop in 12-24 year olds with <20% BMI loss (n=18).
As an Assistant Professor in the Department of Pediatrics Section of Nutrition with a solid publication and grant
funding record, and emerging clinical trial experience, I am establishing myself within the field of personalized
pediatric obesity medicine. I envision future diagnostic tools and interventions for weight management in youth
that are tailored to an individual’s underlying (patho)physiology, values, and socioenvironmental influences. A
K23 would support the following research goals: 1) define physiologic phenotypes underlying MBS mechanism
and cardiometabolic response using robust measures not previously reported in youth, 2) complete the first
randomized controlled trial of a GLP-1 receptor agonist in youth post-MBS, and 3) contribute data from a diverse
cohort that particularly fills gaps in under-represented Hispanic youth. My career development plan is carefully
constructed to 1) learn how to longitudinally perform and interpret core dynamic measures of gut peptides, body
composition, energy balance, insulin sensitivity, and cardiovascular health. Experience with these measures will
yield a versatile toolbox that will be highly translatable to future clinical intervention trials in pediatric obesity. 2)
gain experience with recruitment/retention for a longer study protocol (18 months), and 3) learn how traditional
study designs can inform more nimble adaptive clinical trial interventions for a subsequent R01.

Public health relevance
PROJECT NARRATIVE Adolescents with severe obesity experience significant physical and mental health morbidity, stigma, and premature death. Metabolic and bariatric surgery (MBS) is the most potent treatment available; however, a significant proportion of youth experience ongoing persistent obesity or weight regain after MBS without clear physiologic predictors, which may lead to residual cardiometabolic, mechanical, and psychological risks that must be effectively managed long-term. In the proposed study, we will collect rigorous longitudinal physiologic measures of gut peptides, insulin sensitivity, and cardiovascular structure/function not previously reported in youth after MBS, and will perform the first randomized, controlled trial of semaglutide post-MBS among youth with suboptimal BMI reduction, which in aggregate will refine the definition of MBS success and establish the feasibility and initial efficacy of semaglutide as a potential postoperative treatment adjunct.